Advancing Clinical Science in Pediatric Gastroparesis

Gastroparesis (GP) in children and adults is characterized by delayed gastric emptying in the absence of
mechanical obstruction. GP is associated with significant morbidity and mortality yet little is known regarding its
incidence, prevalence, and natural history in children. This knowledge gap in pediatric GP is exacerbated by the
overlap in symptoms and pathophysiology with functional dyspepsia (FD), a common disorder in adults and
children. The limited data suggests significant differences between clinical symptoms and pathophysiology of
GP and FD in children vs adults. Thus, data regarding GP and FD in adults is unlikely to provide insight and fill
the knowledge gaps regarding GP and FD in children. These issues (among others) underscore need for
childhood GP- and FD-specific research strategies. Thus, the goals of this renewal application are to build on
and extend our previous Pediatric Registry work as part of the NIDDK Gastroparesis Consortium (GpCRC)
(e.g., recruitment into the Registry, development of a pediatric Quality of Life and Symptom GP Module;
PedsQL/Symptom GP Module), ultimately, to determine the factors contributing to disease severity measured
by quality of life and symptoms. Our Specific Aims are:
Aim 1 – Complete validation of the PedsQL/Symptom GP Module via field testing and develop an
analogous module for pediatric FD using qualitative measures followed by field testing.
Aim 2- Determine the role of the following potential contributors to disease severity in pediatric GP
and FD:
2a - Pathophysiologic: a) Visceral hypersensitivity (via water load satiety testing); b) Gastric
accommodation (via intragastric meal distribution); c) Gastric emptying rate (scintigraphy); d) Duodenal/gastric
inflammation (mast cells and eosinophils); e) Gastric/proximal gut barrier function (gut permeability).
2b - Psychosocial distress: Engage with psychologists to assess a) Somatization (Children’s Somatization
Inventory); b) Depression (Children’s Depression Inventory) c) Anxiety (State-Trait Anxiety Inventory); d)
Disability (Functional Disabilities Inventory); e) Catastrophizing (Pain Catastrophizing Scale).
2c - Dietary intolerances: Engage with dietitians, patients, and parents to determine self-identified food
intolerances and eating behaviors in children with GP and FD.
Aim 3 - To accomplish the above, expand Registry recruitment by including more pediatric centers, with some
linked to adult GpCRC sites in order to begin to explore barriers to transition from pediatric to adult care.
This innovative multidisciplinary approach will prospectively begin to fill the vast knowledge void regarding
GP and FD in children. The current proposal is responsive to RFA-DK-20-504 by achieving among other goals,
to: build on our previous gains, enlist expertise of psychologists and dietitians, expand recruitment sites, and
study pediatric to adult care transition.

Public health relevance
PROJECT NARRATIVE - RELEVANCE Gastroparesis and functional dyspepsia affect both children and adults, is responsible for great morbidity, and is associated with increased mortality. Little is understood regarding the epidemiology, causes, and natural history of these disorders in adults but the knowledge void is even greater in children. The results of this proposal will provide novel insights into their clinical expression and course in children.